University of Florida Partnerships Across Interdisciplinary Networks: Training through Engineering, epidemiology & Addiction Medicine (UF PAIN TEAM)

ABSTRACT
In response to RFA-NS-24-015, we propose the University of Florida Partnerships Across Interdisciplinary
Networks: Training through Engineering, epidemiology & Addiction Medicine (UF PAIN TEAM) - a T90/R90
interdisciplinary postdoctoral program designed to train the next generation of independent clinical pain
researchers. Our UF PAIN TEAM training program is built on the unique strengths of our existing CTSI-developed
team training model, adding a pain science emphasis to clinical pain research training and integrating traditional
and non-traditional areas of pain research. We will also emphasize collaboration across the research continuum,
and further expand the scope of interdisciplinary clinical pain research to include disciplines not traditionally
represented in pain research. We will create a unique cohort experience by embedding authentic, collaborative
and interdisciplinary experiences in team science into each trainee’s research, preparing them to conduct team
science clinical pain research locally and across the broader HEAL PAIN Cohort Program. The proposed team
training approach for clinical pain research combines authentic didactic and experiential training in team
science; interdisciplinary mentoring that crosses academic barriers; scientific training across the entire
biopsychosocial model of pain; and career development mentoring that crosses academic disciplines. We will
provide extensive breadth and depth in training to i) 4 post-doctoral scientists (T90; PhD, Dual degree-PhD), and
ii) 1 non-citizen, non-permanent resident clinically-trained PhD holder (R90), that are seeking advanced post-
doctoral training in scientific areas designated as high priority by HEAL. These areas are pain across the lifespan,
nonpharmacological interventions for pain, non-opioid pharmacological treatments for pain, effective
interventions for pain and co-morbidities, impacts of social determinants of health on pain, and advancing health
equity in pain. To accomplish our goals, expert program faculty will provide extensive team training experiences.
Postdoctoral trainees will receive an initial commitment for appointments of two years, where 2 teams of trainees
will work together and develop their own collaborative projects involving disciplines traditionally and not
traditionally represented in clinical pain research. By implementing an integrated team training program, including
didactic, research, and professional development activities, we will equip trainees with new skills, knowledge,
and expertise to apply these skills in collaborative teams. We will also create a culture of responsible research
conduct and professional excellence to ensure that trainees aspire to the high standards of scientific integrity
and quality, which will set the tone for their future careers in clinical pain research. Finally, we will disseminate
elements of our team training model regionally and nationally via interdisciplinary communities of traditional and
non-traditional pain disciplines including the Annual HEAL PURPOSE Network. Collectively, these programs will
produce highly skilled, collaborative, and interactive scientists who can engage in team science to generate new
knowledge and translate discoveries to tangible advances in the prevention, treatment, and cure of chronic pain.

Public health relevance
NARRATIVE Chronic pain represents a major public health problem, and an improved understanding of the biopsychosocial contributors to pain is critical to inform interventions aimed at pain prevention and treatment. At present, there is a need to bolster the dwindling clinical pain research workforce. To address this gap, we propose the University of Florida Partnerships Across Interdisciplinary Networks: Training through Engineering, epidemiology & Addiction Medicine (UF PAIN TEAM) with the long-term goal of creating the next generation of team-trained clinical pain scientists. Working in teams, the UF PAIN TEAM will move the pain field forward through cutting edge research designed to elucidate the causes and reduce the burden of pain.